Unraveling the dynamic mechanisms underlying opioid respiratory depression

Project Summary
Opioid overdose deaths continue to escalate with a large proportion caused by fentanyl overdoses. To explain
why fentanyl is particularly fatal we propose the “triple-hit” hypothesis: Fentanyl targets three distinct but
interacting mechanisms that lead to a fatal apnea: (1) Fentanyl causes wooden chest syndrome (WCS) by
directly exciting motoneurons due to the inhibition of K+-channels; (2) Fentanyl activates tonic inhibitory neurons
that slow rhythmogenesis within the ventral respiratory column (VRC) resulting in the opioid-induced respiratory
depression (OIRD). As the network slows, it preserves the rhythmogenic properties of eupneic breathing, but
WCS and OIRD together drive the network towards the third hit: (3) Hypoxic conditions. While under normoxic
conditions, breathing depends on rotational dynamic interactions among inspiratory and expiratory neurons
distributed along the entire VRC; In hypoxia this network reconfigures, becomes silent and dependent on the
ballistic activation of inspiratory neurons to generate gasping and autoresuscitation.
Although this grant focuses only on these mechanisms, we predict that the three distinct mechanisms will require
distinct interventions to slow OIRD, reduce WCS and prevent or reverse the fatal apnea.
These three distinct mechanisms are explored in three specific aims:
Aim 1 characterizes the fentanyl effects on K+-currents expressed in HEK293 cells to unravel the mechanisms
that activate neurons. In synaptically isolated motoneurons we will then characterize the fentanyl effects that
lead to the activation of the diaphragmatic EMG.
Aim 2 characterizes the opioid-induced transition from OIRD into the fatal apnea: We specifically test the
hypothesis that under baseline conditions respiratory rhythmic activity is generated by a distributed network
along the VRC. We propose that opioids activate inhibitory neurons in the parabrachial nucleus (PBN) and
Kölliker-Fuse (KF) region which in turn inhibit neurons in the VRC and pons. These tonic inhibitory neurons play
a significant role in depressing respiratory rhythmogenesis but they preserve the principle rhythmogenic
mechanisms of the network. This hypothesis is tested with Neuropixel recordings in urethane-anesthetized, as
well as alert freely behaving mice. Viral vectors injected into the medullary and pontine regions will allow us to
optogenetically and chemogenetically manipulate inhibitory and excitatory neurons to assess their contributions
to OIRD and fatal apnea.
Aim 3 will use TRAP2 mice to explore the permanent induction of ASTEp1 Trap2 in neurons that are activated
by opioids versus hypoxia. These mice will allow us to histologically characterize as well as optogenetically and
chemogenetically manipulate neurons that are differentially activated by opioids versus hypoxia.
Aims 1 to 3 complement each other to arrive at a thorough understanding of the network mechanisms that
underlie opioid-induced respiratory depression, wooden chest syndrome and the fatal apnea.

Public health relevance
Project Narrative The goal of this research is to understand three distinct mechanisms that lead to the fentanyl-induced cessation of breathing: The mechanisms underlying wooden chest syndrome (WCS), together with mechanisms underlying opioid-induced respiratory depression (OIRD) result in hypoxic conditions that trigger a reconfiguration of the respiratory network, leading to gasping and fatal apnea. During the transition into the fatal apnea respiratory rhythmogenic mechanisms change, which will require the development of distinct therapeutic strategies.